Learning Health System Embedded Scientist Training and Research Center - Admin Core

Abstract - UCSF E-STaR Administrative Core
The UCSF E-STaR Administrative Core (AC) will provide leadership, management, and operational oversight
for the LHS E-STaR Center. The Multi PI-structured LHS E-STaR Center will be housed administratively within
the UCSF Office of Research, and the MPIs will be responsible for day-to-day operations, assisted by the LHS
E-STaR Center Director and an Administrative Analyst. The AC will coordinate the proposed activities of the
Research and Education Core (REC) and the Research and Data Analysis Core (RDAC), and will serve as the
gateway through which to meaningfully engage with the health system partners, community organizations, and
other stakeholders. The AC will achieve this through completion of the following Specific Aims: Aim 1. To
coordinate the proposed activities and maintain internal information flow for the LHS E-STaR Center.
The AC will deploy a matrixed leadership structure consisting of 3 PIs who will jointly lead strategic and
governance functions of the LHS E-STaR Center, and individually lead each of the E-STaR Center Cores; Aim
2. To ensure effective coordination of stakeholder engagement and integration of E-STaR Center-
supported projects within health system partners. Stakeholder engagement activities include recruitment
of E-STaR Scholars from diverse disciplinary and demographic backgrounds and research mentors from
UCSF and health system partners; promotion of E-STaR Center REC and RDAC support and consultative
functions to partners; solicitation of LHS research opportunities from health system partners; and solicitation
and incorporation of patients, providers and staff perspectives and contributions into E-STaR-supported
projects. To support communication and integration with the E-STaR Center, AC key personnel will include a
health system partner liaison for each of the initial 3 collaborating health systems, UCSF Health, Zuckerberg
San Francisco General(ZSFG)/San Francisco Health Network(SFHN), and the SF Veterans Affairs Medical
Center (VAMC). Liaisons meet the following criteria: actively serve in a health system leadership role, provide
patient care in the health system, and have experience conducting embedded LHS research in the health
system; Aim 3. To measure the outcomes and impact of the E-STaR Center on Scholar, patient,
provider, and health system outcomes. AC key personnel will include a program evaluator experienced in
training program and health system outcomes evaluation using qualitative and quantitative methods; Aim 4. To
communicate and disseminate LHS findings from the E-STaR Center programs and health system
partners to local, state, and national stakeholders, including robust liaison between the Center and
AHRQ/PCORI. AC key personnel will include a communications specialist skilled in dissemination of research
internally and to external audiences. Expected Outcomes are a nimble and durable administration through
which to propel LHS-embedded research across UCSF’s health systems.